UMN Udall Clinical Core

The University of Minnesota (UMN) Udall Center Clinical Core will be led by Scott Cooper PhD, MD and Paul
Tuite, MD. The Clinical Core will recruit 100 patients with Parkinson's disease (PD) who are candidates for
deep brain stimulation (DBS) for the human subjects protocols associated with Projects 1 and 2 and the
Catalyst Project. The Clinical Core will collect pre-surgical baseline and longitudinal motor and non-motor
assessments using NINDS PD-specific Common Data Elements (CDE) as well as DBS programming data.
The Clinical Core will also collect baseline biosamples from enrolled participants for the BioSEND repository to
supplement the CDE’s that Biostatistics Core will enter into the NINDS Parkinson’s Disease Biomarkers
Program Data Management Resource. In collaboration with the University of Rochester Udall Center and Sage
Biometrics, the UMN Clinical Core will collect in-home assessments using the mPower 2.0 smartphone app for
Project 2, extending this app to a new cohort of PD patients with DBS. The Clinical Core will work closely with
the Biostatistics, Administrative, and Imaging Core to support all Center and Project aims.